Core 1: Diagnostic Immunopathology and Imaging Core

ABSTRACT - DIAGNOSTIC IMMUNOPATHOLOGY AND IMAGING CORE
A concerted effort to collect and bank well-characterized high-quality human tissues from the upper
aerodigestive tract, including oral cavity, larynx, and oropharynx, has been an ongoing goal by Pathology at the
MGH and MEE since 1990. Over time, specimen collection has evolved to more specific targeting of tissues
and biologic fluids. Furthermore, the focus is shifting to the stromal component and especially the host
inflammatory reaction including tumor infiltrating lymphocytes. The overall availability of these human tissues
and cells has contributed to the work of many of the investigators participating in head and neck research
efforts and resulting over the years in significant discoveries with high translational impact and numerous peer-
reviewed publications. The Diagnostic Immunopathology and Imaging (DIIC) Core will continue to: 1) collect,
store, process and distribute tissues and biologic fluids for translational research without compromise of patient
care; 2) provide well-characterized tumors with respect to site of origin and World Health Organization
histologic subtype and differentiation; 3) provide normal control tissue in addition to neoplasms; 4) process and
store tissues to address the requirements of all investigators; 5) collect matched blood from pertinent patients
for core projects; 6) provide the specimens in a timely fashion; and 7) provide well-defined mechanisms for
prioritization of the distribution of requested resources to the Program Project investigators.

Public health relevance
NARRATIVE - DIAGNOSTIC IMMUNOPATHOLOGY AND IMAGING CORE The availability of high quality and well-characterized human specimens is central and vital to translational research. The provisions of these specimens through this Core are imperative to the success of the Program Projects.